APOE Orchestrated Molecular Signatures in Aging Brain and AD-the Contribution of APOE2

The inheritance of APOEε4 allele is the strongest genetic risk factor for late onset Alzheimer’s disease (LOAD).
In fact, the inheritance of APOEε4 allele is the strongest known genetic risk factor in human pathology, but the
mechanism is poorly understood. In contrast, APOEε2 allele is protective for AD and age-related diseases AD.
While APOE has been associated with critical cellular functions such as oxidative processes, inﬂammation, glial
cell and neuronal homeostasis, none of those can be dissociated from binding, transport and delivery of choles-
terol and phospholipids to diﬀerent cell types by APOE containing lipoprotein particles. It is also uniformly ac-
cepted that the above functions are APOE-isoform speciﬁc. Our preliminary data demonstrates that phospholipid
composition of APOEε3/3 and APOEε4/4 AD brain differs significantly. Most prominent were changes in lipid
classes that are critical in regulation of normal mitochondrial function and dynamics, but also in execution of
metabolic cascades part of regulated intracellular protein degradation known as autophagy and mitophagy. We
also found significant APOE isoform-specific differences between the transcriptomic profiles of the AD samples
that substantiate molecular explanation of specific AD pathological changes in brain, based on perturbed gene
expression. Our preliminary data also demonstrates that there is a significant difference in the phospholipid
content of native APOE2, APOE3- and APOE4- lipoproteins suggesting that that they may affect differentially
surface immune receptors and initiate different signal transduction cascades.
We hypothesize that the APOE isoform-speciﬁc eﬀects on phenotype are driven by the diﬀerent phospholipid
composition of APOE lipid particles and/or by the diﬀerential eﬀect of APOE isoforms on brain transcriptome and
lipidome. In the First SA, we will establish the association of APOE alleles with AD brain transcriptome and
lipidome and determine the allele specific impact on mitochondrial function and dynamics. We will use postmor-
tem brain samples from AD patients and controls of different APOE genotypes to determine differences in tran-
scriptomes and lipidomes within and between genotypes. We will generate and analyze correlated/co-expressed
gene networks based on APOE allele associated differentially expressed genes and perform correlation analyses
to identify associations between genes and lipids in brain. In the Second SA, we will investigate APOE isoform-
dependent epigenetic and transcriptomic changes in AD brain and APOE Targeted Replacement mice. We will
determine the enrichment of histone marks in specific cell types isolated from human AD and control brains
and will examine APOE allele specific correlations to gene expression profiles. Next, we will examine the
effect of aging on epigenome and transcriptome in distinct brain cell types of human APOE TR mice. In the
Third SA, we will determine how APOE2 lipoproteins counteract the acute deleterious effects of A. The goals
are to examine the effect of APOE2, E3 and E4 lipoproteins on: transcriptome of distinct brain cell populations
and cognition in mice following intracranial injection of A

Public health relevance
Project Narrative / Relevance The role of APOE and its isoform specific effect in neurodegeneration and impaired cognition is poorly understood. The proposed research will determine differences in parenchymal and mitochondrial lipidomes within and between APOE genotypes from AD patients and controls and APOE targeted replacement mice. We will also investigate APOE isoform-dependent epigenetic and transcriptomic changes in AD brain and mice expressing human APOE isoforms. Finally, we will examine how native APOE2 lipoproteins counteract the deleterious effects of A in acute settings. These studies employ newly developed technologies such as transcriptomics by Next Generation Sequencing and lipidomics approaches. The findings will provide valuable information on the biology of APOE isoforms, their role in aging, may aid in developing interventions to prevent, delay or reverse the devastating cognitive deficits in Alzheimer’s disease and may contribute to identifying molecular targets for novel therapeutic strategies.